Peripheral effectors in alcohol-induced stress-susceptibility and blood-brain barrier permeability

Project Summary
Individuals who chronically use alcohol have higher rates of psychological and biological perturbations including
a higher incidence of mood-related disorders, inflammatory diseases, and cancers. Although we often focus on
heavy drinking as being a cause for concern, problematic drinking patterns evolve from recreational use where
repeated alcohol consumption alters homeostatic central and peripheral mechanisms. Recent work has
suggested that the blood-brain barrier (BBB) is a critical interface that supports appropriate reactions to stress-
eliciting stimuli, but how alcohol impacts BBB integrity and the subsequent peripheral/central interactions,
remains largely understudied. Using a rodent model of volitional binge-drinking, I have found that chronic
exposure to alcohol increases peripheral inflammation and promotes stress-susceptibility, even after a protracted
withdrawal period. Moreover, mice with a history of alcohol have increased circulating levels of neutrophils at
baseline and show an exaggerated release of the serine protease, neutrophil elastase, in response to a mild
social stressor. Given the proteolytic nature of neutrophil elastase, I will use novel approaches to identify region-
specific alcohol-induced BBB permeability and characterize the underlying mechanisms contributing to BBB
breakdown with a focus on understanding neutrophil: endothelial cell interactions and how they contribute to
complex mood-related behavioral alterations. Importantly, I have begun to investigate how inhibition of neutrophil
elastase can promote adaptive responses to stress-eliciting situations. The data I have collected thus far support
a novel peripheral mechanism by which alcohol exposure mediates stress-susceptibility and offers insight into
managing peripherally-mediated CNS dysfunction. I am confident that this multifaceted approach will provide the
scientific community with novel insights that can help guide the development of innovative therapeutic
approaches targeting the immune system, which are desperately needed in the field of comorbid substance use
and mood disorders.

Public health relevance
Project Narrative Alcohol abuse and major depressive disorder are often comorbid and have overlapping behavioral and biological pathological characteristics including stress-susceptibility and peripheral inflammation, respectively. The blood- brain barrier (BBB) is a key interface between the central and peripheral nervous system and promotes adaptive responses to stress-eliciting stimuli, however alcohol-induced alterations in peripheral inflammation, including aberrant neutrophil activity, contribute to BBB permeability and facilitate maladaptive responses to social stressors. I will implement novel strategies to characterize the role of peripheral effectors on BBB integrity and advance our understanding of endothelial cell dynamics in stress sensitization.